Co-Targeting IL-6 and CDK4/6 Pathways as a Novel Approach of Preventive Therapy for Triple-Negative Breast Cancer

Triple-negative breast cancer (TNBC) is highly aggressive and is associated with poor clinical outcomes. TNBC
is a major cause of death among breast cancer patients; and is the only subtype of breast cancer that is still
lacking effective prevention and therapeutic options. Development of novel preventive or therapeutic approach
for TNBC is an important task. The priority area of this research project is on women Veteran’s health, in
particular, on women Veterans with TNBC. To assist in this unmet medical need, we propose to
pharmacologically target Interleukin 6 (IL-6) and cyclin-dependent kinases (CDK)4/6 pathways simultaneously;
because IL-6 and CDK4/6 pathways’ co-activation is enriched in TNBC compared to other breast cancer
subtypes. The co-activation is also associated with a shortened time to develop metastasis. Multiple literatures
have reported that IL-6 signaling could confer resistance to anti-cancer drugs; and a report suggests that one of
the mechanisms of resistance to CDK4/6 inhibitors in breast cancer cells is the activation of IL-6/STAT3 pathway.
In addition, our preliminary results show that CDK4/6 inhibitor abemaciclib further induces IL-6 levels in TNBC
cells, which could potentially make abemaciclib-treated TNBC cells more resistance to abemaciclib. Therefore,
co-activation of IL-6 in TNBC with CDK4/6, could potentially compromise the efficacy of CDK4/6 inhibitors and
provide strong rationale to co-target IL-6 and CDK4/6 pathways for effective TNBC preventive therapy. Currently,
no small molecule IL-6 drugs are available in clinical trials. To target IL-6 signaling in TNBC for preventive
therapy, we repurposed a FDA-approved orally bioavailable drug bazedoxifene as a novel inhibitor of the IL-
6/GP130 signaling. Bazedoxifene is marketed as DUAVEE (bazedoxifene with conjugated estrogens) for
preventing postmenopausal osteoporosis. To target CDK4/6 in TNBC, we propose to test abemaciclib (Trade
Name: Verzenio), which is one of the most potent CDK4/6 small molecule inhibitors. Abemaciclib has been
approved by FDA for the treatments of hormone receptor positive, human epidermal growth factor
receptor 2 (HER2)-negative advanced or metastatic breast cancer. Our preliminary data indicate that
bazedoxifene and abemaciclib combination synergistically inhibited TNBC cell viability in vitro and significantly
suppressed tumor growth in vivo. In addition, preliminary results observed that bazedoxifene and abemaciclib
combination prevented liver metastasis in orthotopic tumor model after the primary tumors were removed.
Our central hypothesis is that dual inhibition of the IL-6 and CDK4/6 pathways by bazedoxifene and abemaciclib
combination is an effective approach to prevent TNBC from further progression by suppressing tumor growth
and preventing tumor metastasis and tumor recurrence. We will test the central hypothesis by three specific
aims: (1) Evaluate the activity of bazedoxifene and abemaciclib combination in preventing TNBC tumor growth
and tumor recurrence using clinically relevant TNBC orthotopic mouse model in vivo. (2) Evaluate the efficacy
of bazedoxifene and abemaciclib combination in preventing TNBC tumor metastasis using two complementary
mouse models of TNBC experimental metastasis. (3) Elucidate the mechanisms of action of the bazedoxifene
and abemaciclib combination in TNBC. Successful completion of proposed studies has a potential to delay the
TNBC from further progression and metastasis for years using bazedoxifene-abemaciclib combination as a novel
approach for preventive therapy and presents a unique opportunity to improve patient care and survival for
women Veterans and women actively serving in the military with TNBC.

Public health relevance
Triple-negative breast cancer (TNBC) is a major cause of death among breast cancer patients; and is the only subtype of breast cancer that is still lacking effective chemoprevention and therapeutic options. TNBC subtype has the highest level of both IL-6 and CDK4/6 pathways’ co-activation compared to other breast cancer subtypes; and TNBC patients with high IL-6 and CDK4/6 pathways’ co-activation in their tumors are associated with a shortened time to metastasis development. The development of drugs that co-target IL-6 and CDK4/6 pathways for TNBC preventive therapy is highly desirable and should have a high impact for women Veteran’s health. We propose to evaluate the efficacy of bazedoxifene and abemaciclib combination in suppressing TNBC tumor growth and preventing tumor recurrence and metastasis in complementary mouse orthotopic tumor and metastatic models in vivo. Our long-term goal is to co-target IL-6 and CDK4/6 pathways as a novel approach of cancer preventive therapy for TNBC using two FDA-approved drugs bazedoxifene and abemaciclib.